BehavioraL ActIvation for the PreVention of Post-strokE Depression in LoW-incomE OLder Stroke Survivors (LIVE-WEL)

Post-stroke depression (PSD) affects an estimated 33% of survivors. Subthreshold depression (SD; clinically
relevant depressive symptoms that do not meet diagnostic criteria for a clinical disorder) can affect up to 60% of
stroke survivors and, if untreated, likely progresses to PSD. PSD is associated with recurrent stroke, mortality
(including suicide), neurological deficits, and diminished functioning and quality of life (QOL). Older survivors are
at particularly high risk for PSD owing to age-related life stressors (e.g., chronic disabilities and conditions,
polypharmacy, bereavement, and dependence on others). For low-income, older stroke survivors, financial strain
is an added risk factor for PSD. Treating SD may prevent PSD. However, first-line pharmacological treatment
for PSD prevention can be problematic for older survivors who may fear dependency and can be sensitive to
adverse effects and drug-drug interactions. Behavioral activation (BA) is an efficacious depression treatment
that increases engagement in value-based, reinforcing activities and decreases avoidance behaviors. BA does
not require licensed therapists, is less costly and as effective as cognitive therapy for reducing depression, and
can be modified to effectively target behaviors that have been empirically associated with risk for PSD. The
overall objective of our proposal is to determine the effectiveness of tele-delivered BA by trained lay counselors
(Tele-BA-S) to prevent PSD in low-income, older stroke survivors with SD. We will conduct a randomized
controlled trial (Tele-BA-S vs. treatment-as-usual [TAU]; n=280) with follow-up at 2-months, 4-months, 6-months,
and 9-months after baseline to test the short- and long-term effectiveness of Tele-BA-S. Participants will be low-
income, older (≥ 55 years) first-time ischemic or hemorrhagic survivors (≤ 6 months after stroke) with SD. The
intervention will comprise 5 weekly videoconferenced BA sessions delivered by trained lay counselors,
homework, and 2 monthly follow-up booster calls. Aim 1 is to test the effectiveness of Tele-BA-S vs. TAU on
reducing symptoms of SD and the proportion of survivors that develop PSD (primary clinical outcome). Aim 2 is
to test the effectiveness of Tele-BA-S vs TAU on reducing anxiety, emotional distress, and healthcare visits and
improving QOL and disability (secondary outcomes). Aim 3 is to investigate self-efficacy, motivation, and activity
engagement as mediators of Tele-BA-S effectiveness for reducing symptoms of SD and the proportion of
survivors that develop PSD. Our approach is consistent with National Institute of Mental Health priorities aimed
at reducing mental health disparities in low-income, disabled, and aging populations by establishing the
effectiveness of evidence-based interventions and testing target mechanisms that may account for the
intervention's effects on the clinical outcome. Our results will contribute to an understanding of Tele-BA-S
mechanisms of action to inform future refinement, if needed, of Tele-BA-S. However, if effectiveness is
demonstrated, Tele-BA-S could have a profound effect on PSD prevention.

Public health relevance
Low-income and older age are strongly associated with post-stroke depression (PSD). New and chronic disability, comorbid conditions, polypharmacy, and additional age-related life stressors render first-line pharmacological treatment for PSD prevention more difficult in older stroke survivors. Lay counselors could constitute an accessible and scalable mental health workforce capable of remotely delivering behavioral activation, a modality with demonstrated significant reductions in depression in low-income, older adults, including those with PSD, and preventing worsening symptoms of subthreshold depression and its progression to PSD.